Protocol Specific Research Support (PSRS)

PROTOCOL SPECIFIC RESEARCH The Protocol Specific Research program provides data management and other infrastructure support of novel clinical trials designed and implemented by Kimmel Cancer Center members. These trials are innovative, early phase (I or II), and/or pilot studies testing concepts that are likely to lead to expanded, externally funded studies. Since the last grant submission, the investigators at the Kimmel Cancer Center have been committed to the development of investigator-initiated trials. Institutional funds cover experienced support staff for these trials. Funds are being requested to provide financial support for additional clinical research coordinators for the planned investigator initiated trials (IIT). The area of greatest emphasis has been in the development of innovative first-in-man trials of new agents, in conjunction with therapeutic radiation. These trials are conducted with multi-disciplinary leadership including radiation oncologists, medical oncologists, surgical oncologists, and translational scientists. Over the last 6 years, the number of these trials has increased from 3 to 9 active trials. The 9 multi-modality IIT currently open accounted for 60% of the cancer center therapeutic accrual during 2006. As of April, 2007, there are 3 multi-modality IIT trials under active development. The institution will continue to provide funds to support staff for these IIT trials.